Intercepting the Evolution of Pro-Tumoral Myeloid Cells During the Initiation of Oral Cancer

PROJECT SUMMARY/ABSTRACT
Earlier detection and treatment of human papillomavirus (HPV)-negative head and neck squamous cell
carcinomas (HNSCC) has the greatest potential to improve overall survival rates, which have remained stagnant
at around 50% for several decades. Patients with HPV-negative HNSCC often have a clinical history of oral
epithelial dysplasia (OED), but it remains unclear which lesions will progress to cancer. Through comprehensive
sequencing of these tumors, it is known that a common (about 20%) genetic alteration event is the amplification
at locus 3q26.3, which harbors oncogene SOX2 (SRY-box transcription factor 2). Previous research revealed
that SOX2 inhibits a critical immune sensing pathway by degrading stimulator of interferon genes (STING)
protein in HNSCC cancer cells. The activation of the STING pathway is essential for establishing a spontaneous
anti-tumor immune response, as it promotes the presentation of tumor antigens on the surface of myeloid cells,
leading to the activation of cancer-killing T cells. It remains unclear how STING signaling in tumor-resident
immune cells may be impacted during SOX2-driven malignant transformation. To investigate this, we have
developed a preclinical mouse model to study the transition from OED to HNSCC. Upon high-dimensional
analysis of the immune landscape, we find a unique myeloid cell phenotype that suppresses anti-tumor immune
response. This study will utilize a multipronged approach to investigate the mechanism by which myeloid cells
in SOX2-positive lesions develop terminal suppressive phenotypes. We will test pharmacological and genetic
strategies to intercept the evolution of these pro-tumoral myeloid cells. Ultimately, this project will provide a high-
resolution atlas of functionally distinct myeloid cell subsets in precancerous lesions and identify key interception
points for therapeutic intervention.

Public health relevance
PROJECT NARRATIVE Oral epithelial dysplasia precedes head and neck cancer, presenting an ideal window for early treatment, yet there are limited diagnostic criteria used to predict which lesions will progress to cancer. The interaction between the immune system and the tumor greatly informs treatment response and tumor progression, therefore, this project will investigate the modulation of the immune response at the onset of cancer initiation. This work will describe how immune cells are co-opted in precancerous lesions to promote tumor survival, providing critical information into key therapeutic interception points that may restore anti-tumor immunity at earlier stages of disease.